The Role of Interferon Lambda in Alpha Herpesvirus Neuroinvasion

The Role of Interferon Lambda in Alpha Herpesvirus Neuroinvasion
Project Summary:
Virus infections typically begin in peripheral tissues and usually do not spread to the nervous system (NS)
because it often represents a dead end for both the host and the pathogen. However, some viruses, such as
alpha herpesviruses (e.g., Herpes Simplex Virus-1, HSV-1), have evolved mechanisms to efficiently enter the
peripheral nervous system (PNS) and spread between connected neurons after replicating in mucosal epithelia.
Although much is known about productive infection in epithelial cells and some details of the latency phase in
neurons, the molecular events of viral invasion from epithelial cells to the nervous system and the responses of
peripheral axons to this process are not well understood. This proposal focuses on the initial steps of alpha
herpesvirus invasion of the PNS. We hypothesize that the response of peripheral nerves to cytokines, particularly
interferon lambda (IFN-λ) produced by infected epithelial cells, affects the transport of viral particles in axons
and ultimately determines the establishment of infection (quiescent or productive) in the neuronal nucleus,
impacting the frequency of reactivations.
Preliminary data suggest that axons of peripheral neurons respond to IFNs produced in infected epithelia,
resulting in a non-canonical antiviral state specifically targeting alpha herpesvirus transport. Using this
foundation, we have developed an in vitro latency model by infecting isolated axons with low multiplicity of
pseudorabies virus (PRV) and HSV-1. This proposal aims to elucidate the mechanisms of local axonal responses
to IFN-λ and their effects on viral invasion of the nervous system. Additionally, it seeks to determine how these
initial virus-host interactions influence the mode of infection (latent vs. productive) in neurons and whether
peripheral IFN-λ responses dictate the efficiency of infection establishment.
Our primary hypotheses are: i) axons serve as front-line sensors and responders to viral infection and
inflammation, ii) IFN-λ responses in axons affect alpha herpesvirus particle transport, the establishment of
lifelong infection in neuronal nuclei, and viral spread within the nervous system. To test these hypotheses, we
will leverage state-of-the-art technologies we developed during my previous studies, including: i) tri-chamber
Campenot chambers that physically isolate axons from neuronal cell bodies, ii) live-cell optical imaging to track
entry and subsequent axonal transport of individual virus particles in the presence or absence of cytokines,
inhibitors, or injury, iii) identification of nascent RNA and proteins in neurons, iv) an in vitro latency model to study
the early events in latency establishment.
By understanding the immediate and local responses of PNS axons to incoming virus particles and inflammatory
cytokines before new viral gene products are made, this research will provide deeper insights into how the
nervous system is protected from infection. It will also reveal novel aspects of the molecular basis for latency,
potentially leading to new therapeutic strategies against alpha herpesvirus infections.

Public health relevance
Narrative Alpha herpesvirus infections (e.g. herpes simplex virus 1 and 2; HSV-1 and HSV-2, and varicella zoster virus; VZV) are among the most common virus infections in the world establishing life-long latent infections in the nervous system. There are many host and viral factors affecting the establishment of latency and reactivation that are not well understood. Currently, there is no therapy to block the establishment latency or reactivation, because the available in vitro model systems are not suitable for studying early stages of alpha herpesvirus latency. This project will explore the spread of alpha herpesviruses from axons-to-cell bodies in a controlled setting to reveal viral and neuronal factors affecting the mode of infection and whether local anti-viral responses alter the establishment of infection in the nervous system.